CORE-001 - OPERATIONS CORE

The Operations Core (OC) supports research on multifactorial geriatric conditions by recruiting older adults
who are diverse and representative, engaging older adults from the community as stakeholders, monitoring the
safety of participants, offering resources to support aging research, designing electronic data collection sys-
tems that result in high-quality data, developing software applications to support study workflow and analysis,
and collecting, preparing and reporting data that account for the complexity of multifactorial aging research.
The overall goal of the OC (RC1) is to ensure the successful implementation of multifactorial aging research.
This goal will be accomplished by leading coordinated efforts with OAIC investigators and research staff. The
Specific Aims of the OC are to: (1) provide services to achieve the aims of OAIC-funded and other aging-fo-
cused research projects and the infrastructure to support investigators leading these projects; (2) collaborate to
improve field, data management and informatics methodologies needed to advance aging-focused research on
multifactorial geriatric conditions and to foster the development of the next generation of aging-focused investi-
gators; and (3) conduct innovative Development Projects that advance the mission of the Yale OAIC.
During the current funding cycle (2018-present), the OC provided research support for 16 OAIC-funded
projects and 35 External Projects, consulted with 116 Yale investigators on field and data management plans
for projects and grant submissions, was awarded NIH supplemental funding to build an innovative suite of soft-
ware tools called the Yale Study Support Suite, and collaborated with other Pepper Centers and NIA-spon-
sored programs on research projects, delivery of educational seminars, and software dissemination. These OC
efforts have resulted in 129 publications and more than 30 extramurally funded grants totaling over $150 mil-
lion. During the next funding cycle, the OC will: (1) collaborate on 5 of the 6 proposed REC and PESC projects
and 34 of the 40 funded External Projects; (2) mentor new research staff in the OC; (3) refine and adapt ser-
vices to meet program needs; (4) advise and support investigators on study operations, reporting, and compli-
ance with NIH requirements; (5) broaden the impact of the core by disseminating innovative software products;
and (6) enhance our research informatics infrastructure by working with the OAIC Coordinating Center to iden-
tify funding sources that will permit the further expansion of the Yale Study Support Suite (YES3). The YES3
software will serve as an integral part of study operations support for OAIC projects, and with continued expan-
sion through the proposed Development Project (DP-1), will provide additional tools for analysis, reporting, and
monitoring. The goal of DP-1 is to build the YES3 Datamart REDCap External Module (EM), innovative soft-
ware that will integrate with the YES3 Exporter, an EM developed during the current funding cycle. The new
Datamart EM will further support analysis, monitoring, and reporting of OAIC studies and will be designed to be
compatible with future YES3 components that share data with sponsor and regulatory agencies.